Regulation of Microglial Function by Major Histocompatibility Complex I in Aging and Alzheimer's Disease

Abstract
Understanding the pathological changes that occur with aging and lead to loss of cellular or organ function has
implications for a wide range of age-related diseases. As other diseases and disorders are cured and treated,
life expectancy increases, and the need to increase the ‘healthspan’ is becoming more important. There is a
sterile increase in inflammation with age, known as ‘inflammaging’. This is true with brain aging and is centered
around microglia, the resident myeloid cells of the brain. Our overarching hypothesis is that microgliosis initially
protects against accumulating damage in the aged brain, but with time and Alzheimer’s disease (AD)
neuropathology, persistent hyperactivation becomes deleterious and promotes neurodegeneration. Recently, our
lab has discovered a consistent microglial induction of Major Histocompatibility Complex I (MHC-I) pathway
genes and corresponding receptors (leukocyte immunoglobulin-like receptor subfamily receptors [LILRs] and
paired immunoglobulin-like type 2 receptors [PILRs]) with age and in Alzheimer’s. These receptors are almost
exclusively restricted to microglia in the CNS and could regulate microglial reactivation. Previously, the brain was
thought of as ‘immune privileged’; however, in recent years, it has been discovered that these immune genes
are expressed in the brain, and they often have pleiotropic functions. MHC-I classically presents intracellular
antigens to immune cells to mount an immune response; however, their role in brain aging is thus far unknown.
Microglia become more reactive with age and change to more pro-inflammatory phenotypes. Our hypothesis is
that the increased expression of MHC-I and their receptors is a mechanism through which microglia can signal
cell-autonomously to themselves or cell-non-autonomously to other microglia to induce phenotypic switching to
a more reactive phenotype. Whether this is a protective measure or harmful during aging is unknown, and our
mouse model to block MHC-I function specifically in microglia will allow us to elucidate for the first time whether
this change with aging is beneficial or harmful, and this can provide an avenue for future therapies. Additionally,
this same trend of increasing MHC-I expression with aging has been observed in microglia in various AD mouse
models and human AD cases. As such, we are also investigating the role of MHC-I in the case of AD by crossing
our MHC-I knockout mouse with an AD mouse line to determine the role of this gene in the pathogenesis of AD.
Elucidating the role of these genes in the pathogenesis of AD onset and progression will provide novel insight
into the role of microglia in AD. Using a novel, temporally controlled and microglia-specific MHC-I knockout model
we will: 1) Determine if MHC-I expression regulates microglial reactivity and phagocytic phenotypes with aging,
and 2) Determine if MHC-I suppression exacerbates AD phenotypes prodromally while slowing progression after
symptom onset.

Public health relevance
Project Narrative Neuroinflammation is a hallmark of brain aging and neurodegenerative diseases such as Alzheimer’s and may serve both protective and pathogenic roles. We have identified a highly consistent microglial induction of Major Histocompatibility Complex I (MHC-I) and paired immunoglobulin receptors families with age and AD in mouse and man. This project will explore the hypothesis that MHC-I signals non-canonically (e.g., non-T cell receptor mechanisms) to regulate microglial reactivity with aging and Alzheimer’s.